RED KARD: Reducing Disparities in Knee Arthroscopy for Adolescents

PROJECT SUMMARY
The purpose of this K23 proposal is to facilitate Dr. Neeraj Patel’s development into an independent surgeon
scientist who will partner with communities, generate community-centered input, and design and implement
interventions to reduce inequities in pediatric sports medicine. Hundreds of thousands of youth athletes require
surgery for knee injuries annually. The incidence of operative knee injuries has skyrocketed, but surgery can
be delayed due to late recognition and barriers, such as insurance, language, and difficulty navigating the
healthcare system. Delays may have lifelong effects, including arthritis, persistent instability, poor patient
reported outcomes, and reoperation. There is little patient-centered research on barriers to orthopaedic care,
and none on interventions to reduce disparities in pediatric sports medicine. To accomplish his long-term
goals, Dr. Patel requires training in community engaged research (CEnR), qualitative methods, and
implementation science. He will achieve these training goals through a comprehensive career development
plan that includes strong mentoring, focused didactics, growing collaborations, and experiential training. This
will guide him towards national expertise in disciplines where few orthopaedic surgeons have any background.
His primary mentor is Dr. Rinad Beidas, an international leader in implementation science with extensive
record of federally funded community research and mentorship. The mentoring team also includes a diverse,
multidisciplinary group of researchers with complementary expertise: Drs. Namratha Kandula (CEnR and
intervention design), Matthew Davis (pediatric CER and population health research), and Julie Johnson
(qualitative methods). Dr. Patel’s development will be bolstered by the robust resources of Lurie Children’s
Hospital and Northwestern University. The proposed study will focus on Hispanic children, a growing
population nationally and 38% of the Chicago’s children, who are at increased risk of delayed knee surgery
and its sequelae compared to white, non-Hispanic patients. The overall objectives are to identify barriers to
timely knee surgery in Hispanic athletes and develop an intervention to implement evidence on expedient
treatment. Under the lens of the Health Equity Implementation Framework, the specific aims are to: (1) identify
barriers and facilitators to timely care of knee injuries for Hispanic high school athletes; (2) design an evidence-
based, culturally-tailored intervention for Hispanic athletes, families, and coaches to reduce delays in
evaluation of acute knee injuries via user-centered principles; and (3) evaluate feasibility, acceptability, and
appropriateness of the culturally-tailored intervention in a pilot study of Hispanic youth soccer leagues. The
proposed aims will drive creation of a future community trial of a culturally-tailored intervention, which will be
the basis for R03 and R01 funding applications. In the process, Dr. Patel will become an expert in CEnR,
qualitative methods, and implementation science, establishing him as one of the only orthopaedic surgeons
conducting health equity CER and a resource for others seeking to address orthopaedic disparities.

Public health relevance
PROJECT NARRATIVE Although the frequency of athletic knee injuries in children has skyrocketed, delayed surgery due to multilevel barriers can have lifelong consequences. This project will identify barriers to timely surgery in Hispanic high school athletes and design and test an intervention to reduce delayed treatment. In the future, the knowledge and intervention developed in this study will be adapted to address similar disparities in other communities, resulting in more equitable care for all youth athletes.